Language, physiology, and anxiety across contexts in autism spectrum disorder and fragile X syndrome

Project Summary/Abstract: Not required for this Administrative Supplement.

Public health relevance
Narrative: Not required for this Administrative Supplement.